RECOMBINANT HGH VS PLACEBO FOR HIV ASSOCIATED WASTING

The goals of this study are to compare the efficacy of recombinant human growth hormone (Saizen) with placebo in the treatment of HIV-associated wasting and to determine if HIV-associated wasting can be reversed, leading to increase body weight and functional capacity as compared to untreated patients.